Opportunity Fund Management Core

The Specific Aims of the Opportunity Fund Management Core (OFMC) of the Stanford CCHI are to: 1) Establish an administrative structure that will facilitate communication with the CCHI Steering Committee regarding priorities and goals for funding; 2) Establish procedures for soliciting, evaluating, prioritizing, and selecting the projects chosen for Opportunity Fund support; 3) Monitor the disbursement and tracking of Opportunity Fund awards, providing reports on the status of the Opportunity Fund at requested intervals or at least annually. 4) Ensure that all projects supported from the Opportunity Fund comply fully with all applicable Federal regulations, policies, and guidelines for research involving human subjects, including the evaluation of risks and protections in projects and appropriate ethical oversight.

Public health relevance
RELEVANCE (See instructions): The CCHI Opportunity Fund provides a mechanism for support of resources such as technical expertise, access to specific high-cost instrumentation, bioinformatics etc. for cooperative projects involving CCHI investigators. This Opportunity Fund Management Core will follow the recommendations of the CCHI Steering Committee to set the goals, priorities and evaluation criteria for the use of the Opportunity Fund.